Single-cell transcriptomic analyses in unravelling aging-dependent mechanisms of aspirin in colorectal cancer prevention

PROJECT ABSTRACT
Colorectal cancer (CRC) is the third leading cause of cancer-related death in the US, with pronounced
disparities in mortality by race and ethnicity. Disparities are particularly pronounced in Alaska Native and
African American people with mortality rates being 2 to 3 times higher. These disparities cannot be explained
by access to care alone, suggesting other contributing factors like molecular subtypes and cellular
heterogeneity, need to be uncovered. Tumor profiling study in patients from multiple racial and ethnic groups
will lead to novel biological insight into CRC, which greatly overcomes the limitation of previous studies that
were conducted predominantly in non-Hispanic white people only. Tumor immune contexture, which refers to
the spatial organization and density of the immune infiltrates within the tumor microenvironment, is complex
and associated with cancer prognosis. Beyond bulk analysis, cutting-edge spatial single-cell analyses enable
us to evaluate tumor immune contexture within different regions of tumor tissues (e.g. margin, center), which
will add our knowledge of immune evasion and antitumor immunity that is critical for CRC survival.
My objective is to better understand the molecular and cellular landscapes driving tumor progression in a
racial- and ethnic-sensitive manner. This will provide me with hand-on, multi-disciplinary training in the new
field of integrative tumor epidemiology. I will leverage data from a nested case-control study that includes 840
Alaska Native, African American, Hispanic and non-Hispanic White CRC patients. Each racial and ethnic group
includes 70 lethal cases who died of CRC and 140 CRC controls who survived at least as long as the case to
which they are matched for age, sex and stage. In the F99 phase, I will examine molecular signatures and
develop a prognostic index across four racial and ethnic groups using RNAseq data. I will evaluate tumor
immune contexture among Alaska Native patients using spatial-resolved single-cell technology (Akoya
PhenoCycler). In the K00 phase, I will integrate transcriptomic and single-cell data into patient-level data to
characterize tumor heterogeneity and its role in other prognostic factors (e.g. treatment, recurrence).
Results from this project will capture a full spectrum of CRC transcriptional and cellular biology and their
relationship to disease outcomes through a spatial lens and provide clinical-useful prediction tools for
prognosis that can be tailored to racially- and ethnically-diverse patients. This will help to address longstanding
racial and ethnic disparities in CRC mortality. This project provides me with training opportunities to develop
expertise in 1) molecular epidemiologic working with racial and ethnic diverse populations, especially with the
engagement of Alaska Native people, 2) cancer immunology, 3) statistical and computational analysis in high-
dimensional data. Those experiences will greatly help my transition into a post-doctoral fellow and eventually
an independent cancer researcher in the rapidly growing field of integrative tumor epidemiology.

Public health relevance
PROJECT NARRATIVE Persistent racial and ethnic disparities in colorectal cancer (CRC) mortality remain a public health concern. Focusing on survival, this project will identify novel biomarkers and create a prognostic index that suggests therapeutic targets and more precise patient stratification for personalized treatments, with the potential to improve outcomes in CRC patients that may particularly benefit those racial and ethnic groups with high CRC mortality. This research will provide me with cutting-edge cross-disciplinary research experience in the rapidly growing field of integrative tumor epidemiology.